Support for National Primate Research Center

OVERALL
ABSTRACT
The Oregon National Primate Research Center (ONPRC), located on the West Campus of Oregon Health &
Science University (OHSU), requests funds to renew grant P51--OD011092 for the next five-year period (May
1, 2024--April 30, 2029). Currently, in its 63rd year of operation, the ONPRC has served a broad range of local,
regional, and national investigators performing biomedical research in nonhuman primate (NHP) models with
the goal of improving human health. The goals for the next funding period are reflected in the following Specific
Aims: 1) Conduct state-of-the-art research in a clinically relevant animal model that advances human health
through understanding the causes of disease and the development of preventions, treatments and cures; 2)
Provide exceptional NHP expertise and services to researchers at the local, regional, and national levels to
advance translational research programs; 3) Pursue the highest standards of humane and responsible animal
care; and 4) Mentor and train the next generation of translational NHP researchers and educate the public
about the importance of biomedical research. To accomplish these aims, support is requested in seven broad
areas. These areas are: 1) Administration, which provides the administrative and service support required for
all aspects of the ONPRC (Governance, Director’s Office, Business Services, Facilities, Improvements and
Modernization, Information Systems, Research Library, and Environmental Health & Safety); (2) Animal
Services (Behavioral Services; Clinical Medicine; Compliance, Education and Training; Operations; Pathology
Services; Surgical Services; Resources & Logistics; as well as the NHP Resources that include Aging,
Infectious Disease, Obese, and Precision Medicine); (3) Core Support Services (Research Cores that included
Assisted Reproductive Technologies, Bioinformatics & Biostatistics, Endocrine Technologies, Flow Cytometry,
Integrated Pathology, Magnetic Resonance Imaging (MRI), Molecular Virology, and Primate Genetics); (4)
Scientific Units, including support for Scientific Divisions (Metabolic Health & Disease, Genetics, Neuroscience,
Pathobiology & Immunology, and Reproductive & Developmental Sciences); (5) Pilot Research Program; (6)
Outreach and Community Engagement; and (7) NPRC Consortium--Based Activities. ONPRC’s overarching
goal is to develop, study, and share NHP models that can inform the causes of human diseases, leading to
better preventions, treatments, and cures. The ONPRC achieves this goal by supporting translational research
and expertise in models that are provided locally, regionally, and nationally on a collaborative basis. ONPRC
research support and accomplishments consistently ‘top the list’ relative to other research departments,
centers, and institutes at the host institution, OHSU. Thus, the University recognizes the importance of ONPRC
and has pledged to continue to support its programmatic and infrastructure development.

Public health relevance
OVERALL PROJECT NARRATIVE The Oregon National Primate Research Center (ONPRC) is an established national resource whose primary mission is to improve human health and quality of life through exceptional nonhuman primate (NHP) research programs. The ONPRC maintains the facilities, expertise, and infrastructure required to conduct the most advanced biomedical research using NHPs in a collaborative and interdisciplinary manner that leads to novel therapies and cures for human diseases.